E protein targets orchestrating γδ development and function

PROJECT SUMMARY/ABSTRACT - PROJECT 1
T lymphocytes comprise two major lineages,  and , which play critical, partially-distinct roles in host defense.
 and  T cells arise from a common progenitor in the thymus; however, the molecular processes responsible
for specification of these lineages during development in the thymus remain incompletely understood and this
represents a major gap in knowledge. We seek to address this knowledge gap. In doing so, we have provided
compelling evidence that specification of the  and  T cell fates is controlled by differences in T cell receptor
(TCR) signal strength. These signaling differences regulate fate by proportional induction of Id3, which causes
graded repression of the function of E box DNA binding proteins (E proteins; E2A and HEB). Nevertheless, the
targets through which these E proteins regulate  T lineage commitment and effector fate specification remain
unclear, and this presents a major gap in knowledge. To address this knowledge gap, we (all Projects) employed
a comprehensive, genome-wide approach, which revealed a number of important insights into the mechanism
by which strong TCR signals remodel E protein binding to specify fate. First, strong TCR signals have selective
effects on E proteins, markedly repressing E2A binding to the genome, while preserving HEB binding (all
Projects). The sparing of HEB binding is important because HEB function is required for development of
interleukin-17 (IL-17) producing  T cells (Proj1/3/4). Second, we have identified Tcf7/TCF1 as both a novel E
protein target and a critical cofactor that cooperates with E proteins in controlling  lineage commitment.
Consequently, in the current proposal we seek to address two major questions relating to how E proteins control
TCF1 expression and the targets through which they cooperate to control lineage fate. We will do so according
to two aims: Aim1 seeks to interrogate the mechanism by which 3 critical E protein bound elements (EPE) near
the Tcf7 locus regulate Tcf7/TCF1 expression and whether individual E protein family members (E2A, HEBCan,
and HEBAlt) play distinct roles. In Aim 2, we will focus on the E/TCF targets through which the  lineage fate is
facilitated. We have determined that many of the E/TCF co-bound targets regulate cell metabolism and  lineage
commitment is coupled with changes in lipid composition. We will employ a series of gain and loss of function
strategies to explore the importance of these targets in regulating  lineage commitment and peripheral effector
fate. In addition, we will profile at a genome-wide scale how the reduction in TCF1 expression caused by strong
TCR signals cooperates with E protein remodeling to specify the  lineage fate. We will do so using a novel
method termed STARR-Seq (with Project 2 and Core B) that interrogates the regulatory element repertoire at
a genome-wide scale in single cells. Consequently, in the current proposal, we integrate the expertise of all
Project leaders and the Genomics Core to elucidate the mechanistic basis by which changes in E protein
binding controls  lineage commitment and adoption of the IL-17 effector fate and determine how the molecular
remodeling in mouse model systems aligns with that during development of human  T cells (Proj2).